NF-kappaB in pathogenesis and therapy of head and neck cancer

As part of The Cancer Genome Atlas group characterizing head and neck cancer, we have identified components of the classical and alternative NF-kB, PI3K, and Notch pathways as candidate genetic drivers for aberrant NF-kB activation and defects in death signaling. We have reported that decreased TRAF3 contributes to aberrant activation of the alternative NF-kB pathway, which promotes migration of HNSCC. We have shown Notch1 mediates non-canonical activation of IKKalpha and NF-kB signaling in cutaneous squamous cell carcinoma stem cells. A clinical trial with PI3K-mTOR inhibitor rapamycin has completed accrual and been submitted for publication. Studies using a genome wide RNAi screen employing NF-kB reporter lines have identified potential drug targets promoting NF-kB activation, under investigation.